The Population Research Institute: Administrative Core

Project Summary: PRI Administrative Core The Administrative core is the organizational hub of the Population Research Institute (PRI) and supports research in all of PRI’s primary research areas to advance the scientific understanding of human population dynamics. The Administrative core coordinates activities and manages general operations. The Administrative core provides leadership and management that ensures PRI functions as an engaging setting for research collaboration and dissemination. The core is directed by the PRI Director and the Managing Director. The Administrative core’s specific aims are focused on maximizing research efficiency and minimizing administrative burden for researchers. The specific aims of the Administrative core are: (1) To manage PRI’s general operations including financial resources, facilities and staff vital to supporting the scientific mission of PRI; (2) To provide comprehensive services from project inception to completion that increase research productivity and impact; (3) To coordinate the administrative needs for interdisciplinary research teams that span institutions and include population scientists beyond PRI; (4) To advocate for resources and disseminate PRI’s contributions to population science within the Pennsylvania State University and in the scientific community more broadly. The activities of the Administrative core are designed to improve the productivity and impact of population science research across PRI’s four primary research areas and reduce administrative burden for researchers. Through efficient management processes, the Administrative core increases researchers’ competitiveness for external funding and raises the impact of their research on improvements in human population health and wellbeing.

Public health relevance
Project Narrative – Administrative Core. Not applicable